Mechanical Information Processing from Sub-cellular to Tissue Scales

Project Summary
Mechanical Information Processing from Sub-cellular to Tissue Scales
The mechanical behaviors of cells control diverse physiological processes including cell
proliferation, migration, fate and apoptosis; these behaviors are also key contributors to
pathologies such as cancer and cardiovascular diseases. Within multicellular tissues, cell
mechanics are largely determined by feedback mechanisms, which coordinately regulate the actin
cytoskeleton, cell-matrix adhesions, and cell-cell adhesions. It has become evident that
cytoskeletal assemblies are complex mechanochemical systems that employ force-sensitive
biochemical regulation to maintain and modulate mechanical response. While the basic
architectures of these systems have been suggested, approaches are needed to understand their
force-sensing and responses. This will elucidate the mechanical design principles of the
cytoskeleton, enabling novel methods for the engineering of a cell or tissue’s shape and
dynamics. To address this challenge, my research program leverages an innovative combination
of analytical methods: cell biophysics, molecular cell biology, live cell imaging, mathematical
modeling, and optogenetics, allowing us to investigate the machines and materials constructed
within the cytoskeleton of adherent cells. Our goals over the next five years are to expand the
understanding of adherent cell mechanics and mechanobiology. We will explore the underpins of
the force-sensitive remodeling of cell-cell adhesions and the role it plays in contact inhibition of
proliferation. We will also investigate mechanisms of mechanosensing via LIM domain proteins,
a new class of force-sensors within the actin cytoskeleton. We will develop new experimental
approaches with which to probe the mechanochemical circuitry within cells, including establishing
a new field of data-driven biophysics modeling. Thus, our work will broadly impact the field of
cellular biophysics and mechanobiology.

Public health relevance
A fundamental challenge in modern cell biology understanding how cells sense and process mechanical signals to control their physiology. We propose a MIRA award to continue our efforts in advancing the understanding of mechanical information processing in multicellular tissue. This award will forward our understanding of cell adhesion, cytoskeletal mechanics, tissue biology, and cell mechanotransduction. More broadly, it will develop approaches which with to advance the greater fields of cellular biophysics and mechanobiology.